Receipt of GLP-1 Receptor Agonists Among Rural Patients with Obstructive Sleep Apnea

Project Summary/Abstract
Excess weight is the greatest modifiable risk factor for the development of obstructive sleep apnea (OSA).
Successful weight management improves OSA severity and symptoms but is hard to achieve. Weight
management pharmacotherapy and bariatric surgery are effective adjunctive strategies, but our analyses
indicate they are rarely delivered. Delivery of these health services is particularly low among patients living in
rural settings, who already face a greater comorbidity burden relative to urban peers. Glucagon-like Peptide-1
receptor agonists (GLP-1RAs) are recently FDA-approved medications that dramatically increase the rates of
clinically meaningful weight loss, improve comorbidities, and reduce OSA severity. Due to their favorable
toxicity profile and less intensive monitoring, GLP-1RAs are a scalable treatment that may help bridge the gap
to rural areas. However, early evidence suggests GLP-1RAs are underutilized. We hypothesize that rurality will
be independently associated with lower usage for GLP-1RAs for chronic weight management among patients
with OSA and excess weight, while accounting for other patient-, provider-, and health system factors
embedded in the Access to Care Model. Informed by domains of the Health Equity Implementation Framework,
we also anticipate that patient and provider perspectives will identify multi-dimensional barriers to GLP-1RA
access and delivery. The specific aims of this mixed methods proposal are to: 1a) Test the association of
rurality with initiation of GLP-1 RAs among patients with OSA and excess weight; 1b) Test the association of
rurality with discontinuation of GLP-1 RAs among patients with OSA and excess weight; and 2) Examine
perspectives of patients, sleep specialists, and primary care providers to understand the barriers and
facilitators to GLP-1RA use among rural patients with OSA and excess weight. These aims will be completed
using a national cohort of patients with OSA and excess weight assembled from administrative data within the
Veterans Health Administration (VHA). This proposal will identify intervenable barriers to weight management
care among rural patients with OSA and excess weight in order to develop strategies to overcome these
barriers. Dr. Leonhard will achieve his training aims of gaining expertise in advanced biostatistical and
epidemiologic methods, qualitative research methodologies, and employing health equity frameworks through
the completion of this project. He will be well supported in his training environment at the University of
Washington and the Veterans Affairs Health Systems Research Center of Innovation for Veteran Centered and
Value Driven Care. He will be mentored by a multidisciplinary team with a strong track record of collaborative
mentorship and with extensive experience in quantitative and qualitative research, health systems research,
and research to reduce disparities in the delivery of care. These resources will prepare Dr. Leonhard to
become an independent health systems investigator whose work improves care delivery for patients with sleep
and pulmonary disorders in ways that achieve patient-centered outcomes and reduce disparities.

Public health relevance
Project Narrative Glucagon-like Peptide-1 receptor agonists (GLP-1RAs) are a newer and increasingly popular method for chronic weight management and show great potential in the treatment of obstructive sleep apnea (OSA). But substantial challenges exist to the delivery of effective weight management care among patients with OSA and excess weight that live in rural areas. This project will evaluate the barriers and facilitators to the use of GLP- 1RAs to improve the reach and delivery of these promising new weight management pharmacotherapies.